Contract Orientation and Kickoff Meeting in support of IDIQ - Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients (R&D services)

Contract Orientation and Kickoff Meeting in support of IDIQ Preclinical Pharmacokinetic and Pharmacology Evaluations of Agents Being Developed for Cancer Patients